Equipment items to enhance operations at the BioCAT Facility at the Advanced Photon Source

The purpose of this administrative supplement request is to acquire “Equipment items to enhance operations at
the BioCAT Facility at the Advanced Photon Source”. These items were identified as required to meet unmet
needs by our users that were not anticipated in the parent P30 proposal. These include a fluorescence
microscopy system, a Wyatt Eclipse system for Flow Field Fractionation, a Newport Hexapod motors for
Compound Refractive Lenses and a Nanodrop OneC Microvolume UV-Vis Spectrophotometer.

Public health relevance
The BioCAT resource will continue to provide state-of-the-art facilities with unique capabilities for muscle/fiber diffraction and macromolecular SAXS to the bio-medical and structural biology community. The purpose of this proposed administrative supplement is to acquire equipment that will meet unmet needs of the user community to Enhance the quantity and quality of data.